Center for Appalachian Research in Environmental Sciences - Analytical Chemistry Core for Environmental Sciences (ACCESS)

PROJECT SUMMARY- Analytical Chemistry Core for Environmental Sciences (ACCESS)
The University of Kentucky Center for Appalachian Research in Environmental Sciences (UKCARES)
ACCESS will provide Center investigators with priority access to biological and
environmental sample analysis using state-of-the-science technologies, services, and
instrumentation for studies related to the UK-CARES’ three science themes: Health Impacts of
Waterborne Contaminants (WATER); Health Impacts of Indoor and Outdoor Airborne
Contaminants (AIR); and Emerging Environmental Health Threats (EMERGING THREATS).
To optimize efficiency, ACCESS uses the following two existing laboratory facilities to leverage
resources available to these facilities and extend the capabilities ACCESS: the Environmental
Chemistry and Toxicology Laboratory (College of Agriculture Food and Environment) and the Small
Molecule Mass Spectrometry Facility (College of Medicine), to measure organic chemical
environmental pollutants, trace-elements, their metabolites, and related molecules of interest to
UK-CARES investigators. Effective use of these facilities by UK-CARES investigators will require
both routine analysis and new method development and validation. Specifically, Aim 1 of ACCESS
is to provide measurements of panels of environmental chemicals. We will provide technically
robust methods for detection and quantification of a range of halogenated organics:
polychlorinated biphenyls, dioxins, trihalomethanes and haloacetonitriles, per- and polyfluorinated
alkyl substances, non-halogenated organics including flame-retardants, environmental
phenols, and trace-elements, to support EHS research across the translational spectrum. Aim 2 is
to develop or adapt novel methods to support ongoing needs of UK-CARES investigators. Methods
will be developed de novo or adapted from the literature. We will use our Thermo TSQ Altis Plus
triple stage quadrupole mass spectrometer to develop and validate survey methods that can
profile environmental chemicals in multiple classes using a single analytical workflow and use
high-resolution MS methods employing our Thermo Exploris 240 orbitrap mass spectrometer
for untargeted profiling of environmental chemicals in relevant matrices. Techniques for spatial
analysis, microanalysis, and speciation analysis of trace-elements are refined for environmental
health studies using our Agilent 7900 ICP-MS and associated peripherals. Aim 3 is to work with
administrative and data management functions of the Center to enable robust fiscal oversight,
project management, sample tracking and data reporting. We will work in tandem with the
Integrated Health Sciences Facility Core and the Administrative Core to ensure that Center
members receive priority access, that the activities of ACCESS are aligned with the UK-CARES
strategic vision of the three science themes, and that services and outcomes are tracked through
the online IHSFC Research Support Portal. ACCESS will provide reliable, technically robust
methods and services while pursuing opportunities for innovation. Services provided by the core
will support UK-CARES members’ efforts to make innovative contributions to environmental health
science.